PFAS and bone health over the life course in Hispanic/Latinos: emerging risk factors and underlying mechanisms

ABSTRACT
Latinos, one of the largest and fastest growing ethnic groups in the country, face a disproportionate burden of
osteoporosis, with over 40% estimated to have low bone mass. The underlying environmental factors
contributing to these disparities remain unclear. Per- and polyfluoroalkyl substances (PFAS) are ubiquitous,
persistent chemicals and are emerging as potential risk factors for bone toxicity. Animal and autopsy studies
have shown that PFAS can accumulate in skeletal tissues, potentially influencing bone metabolism through
alterations in osteoclast and osteoblast activities and bone remodeling pathways. However, evidence from
human studies is limited, often hindered by small sample sizes, cross-sectional designs, and a lack of focus on
the Latino population, which bears a disproportionate burden of metabolic and bone diseases. Additionally, no
studies have utilized omics biomarkers to explore the biological mechanisms through which PFAS may affect
bone health. To address these critical knowledge gaps, we propose the first prospective study to investigate the
effects of PFAS on bone mass, metabolism, and structural quality in a high-risk, overweight/obese Latino
population. This study will integrate data from three longitudinal cohorts spanning the life course to understand
the impact of PFAS at various stages of bone development and deterioration. Given the challenges of observing
a single population over 70 years, this multi-cohort design provides the most effective approach for life course
analyses. We will employ robust longitudinal assessments, including bone mineral density (BMD), markers of
bone turnover (BTM), and trabecular bone score (TBS), to document the effects of PFAS across different life
stages in overweight/obese Latinos. Additionally, we will use proteomics to comprehensively characterize
dysregulated pathways affecting bone health, focusing on inflammation and metabolism-regulating proteins. Our
specific aims are: 1) Determine the associations between plasma PFAS concentrations (individual PFAS and
PFAS mixtures) and measures of bone health (BMD, BTM, and TBS) in Latino adolescents, young adults, and
older adults; 2) Investigate the association between plasma PFAS concentrations and plasma protein abundance
related to inflammation, bone morphogenic, and maintenance pathways across different age groups; and 3)
Develop integrated risk profiles of impaired bone health in Latino populations across the life course. By
leveraging three distinct, well-phenotyped cohorts and employing state-of-the-art omics and data science
methodologies, this study aims to elucidate the impact of PFAS on bone health throughout the life course. The
findings have the potential to inform the development of precision environmental health strategies to identify
high-risk individuals and mitigate adverse effects on bone health, thus reducing the overall risk of osteoporosis.

Public health relevance
PROJECT NARRATIVE Per- and polyfluoroalkyl substances (PFAS) are emerging risk factors for osteoporosis, yet the mechanisms identifying how these ubiquitous chemicals impact bone health remain poorly characterized. By integrating data from three longitudinal cohorts spanning different life stages, we seek to uncover the specific ways PFAS affect bone development and deterioration. The insights gained will inform targeted prevention strategies tailored to high-risk groups, enhancing overall bone health.